Molecular and Cellular Basis of PCB Developmental Neurotoxicity

PROJECT SUMMARY/ABSTRACT
Polychlorinated biphenyls (PCBs) remain a significant risk to human health, and a primary target of concern is
the developing brain. Research on PCB developmental neurotoxicity (DNT) has focused almost exclusively on
the higher chlorinated (HC)-PCBs; in contrast, our understanding of the potential for LC-PCBs to interfere with
neurodevelopment is extremely limited. This is a troubling data gap in light of our discovery during the previous
project period that the LC-PCBs 11 and 28 comprise >70% of the PCBs in the serum of pregnant women at
increased risk for having a child with a neurodevelopmental disorder (NDD). We found that PCB 11 and its
metabolites formed via cytochrome P450 (CYP)-mediated oxidation promote dendritic and axonal growth in
vitro. These effects are observed at PCB 11 concentrations relevant to the human gestational environment,
and the potency of the metabolites varied from that of the parent. Our preliminary data suggest that PCB 11
causes DNT via activation of CREB-dependent signaling pathways. Whether the metabolites alter
neurodevelopment via the same molecular mechanism is not known. These findings, which were the first to
identify the DNT potential of LC-PCBs, raise several critical questions that must be addressed to define the risk
that LC-PCBs pose to the developing human brain: (1) Do LC-PCBs found in the gestational environment alter
neurodevelopment in the intact brain? (2) What are the molecular mechanism(s) by which LC-PCBs alter
neuronal morphogenesis? (3) Does human CYP-mediated metabolism activate LC-PCBs to developmental
neurotoxicants? To address these questions, we will test the central hypothesis that CYP-mediated
metabolism influences the in vivo effects of LC-PCBs on CREB-dependent neurodevelopmental processes. To
test this novel hypothesis, we will leverage state-of-the-art mouse models engineered to express human
CYP2A6 or CYP2B6 but not mouse Cyp2a, 2b, 2f2, 2g1, and 2s1 proteins (Cyp2abfgs-null mice). Focusing on
LC-PCBs documented in the human gestational environment and developing brain, we will (a) identify the LC-
PCB metabolites formed via human CYP2A6 and CYP2B6, and test their effects on CREB-dependent
neurodevelopmental processes in primary neuron-glia co-cultures; and (b) determine how modulation of LC-
PCB metabolism influences the dose-response relationship of LC-PCB DNT in vivo. The anticipated outcomes
of these studies include the identification of LC-PCBs as a new class of environmental contaminants that
interfere with neurodevelopment and novel mechanistic data regarding the role of CREB signaling and CYP-
mediated bioactivation in PCB DNT. This research will impact public health not only by generating data
critically needed to assess the risk LC-PCBs pose to the developing brain, but also by providing critical
mechanistic insights regarding the plausibility of dietary and/or pharmacological manipulation of CYP activity to
mitigate DNT risk in vulnerable subpopulations.

Public health relevance
PROJECT NARRATIVE The proposed research will quantify the developmental neurotoxicity of lower-chlorinated polychlorinated biphenyls (LC-PCBs) found in the human gestational environment and investigate how metabolism by human cytochrome P450 enzymes influences neurotoxic outcomes in experimental animals exposed to LC-PCBs in the maternal diet throughout gestation and lactation. These outcomes are relevant to public health because they will provide data critically needed to assess the risk these emerging environmental contaminants pose to the developing brain and they will provide insights regarding strategies for mitigating this risk in vulnerable human populations. Therefore, the proposed research is pertinent to the part of NIH’s mission that seeks to develop fundamental knowledge about living systems to enhance health and reduce the burden of human disease.